Characterization of the role of super-enhancers in ovarian cancer treatment response

Project Summary: Despite advances in our understanding of the underlying genomic landscape of high-
grade serous ovarian carcinoma (HGSC), few new targeted treatments have entered clinical care with
significant survival benefit. Super-enhancers (SEs) are epigenetic features previously understudied in HGSC
that are targetable with a variety of drugs. In cancer, SEs regulate expression of oncogenes such as MYC, but
the specific set of oncogenes regulated by SEs depends on the cancer type, and these have not been
previously defined in HGSC. Preliminary data suggests that SEs underlie the oncogenic functions of ovarian
cancer, as SE-targeting drugs such as triptolide and bromodomain inhibitors are effective in ovarian cancer
models in vitro and a rare ovarian cancer subtype in vivo. The work proposed here will lead to new
understandings of how SEs influence HGSC growth and therapy response, and how HGSC might be better
treated with new therapeutic strategies targeting SEs, ultimately improving outcomes for patients with HGSC.
Hypothesis: Based both on the proven role of SEs in the pathogenesis of other cancers through unique
regulation of oncogenes and also on data showing sensitivity of HGSC to SE-targeting drugs, this proposal
tests the hypothesis that SE dysregulation plays a central role in HGSC tumorigenesis and treatment
response. Specific Aims: Aim 1: Map HGSC SEs contributing to oncogenic phenotypes. Aim 2: Determine
dynamic SE modification following standard-of-care treatment. Aim 3: Evaluate the efficacy of SE-targeting
drugs in HGSC. Study Design: To identify HGSC-specific SEs, six serous HGSC cell lines and twenty tumors
will be examined by RNA-Seq and ChIP-Seq for H3K27 acetylation. SEs will be identified both bioinformatically
and through functional characterization for roles in cell proliferation and response to chemotherapy using the
CRISPR interference system. In the independent phase of this award, the dynamics of SEs will be assessed in
response to platinum treatment and SE-targeting drugs will be tested as single agents and for synergy in
combination with platinum-based chemotherapies in HGSC cell lines, patient-derived xenograft organoid
models, and animal xenograft models of HGSC. Career Development: Towards the goal of becoming an
independent investigator studying novel therapies for ovarian cancer treatment, this proposal has also
assembled a career development plan. This includes K99 phase mentorship by leaders in genomics (Dr.
Jeffrey Trent, mentor) and ovarian cancer (Dr. Lorna Rodriguez, co-mentor) and an advisory team that
includes experts in bioinformatics, super-enhancers, and ovarian cancer. As an institute, TGen provides all the
scientific support, facilities, and equipment necessary to complete this project. TGen has a structured plan for
responsible conduct of research training and other professional development. Additional coursework in
bioinformatics analysis of ChIP-Seq and RNA-Seq data is built into the plan, as well as attendance at relevant
national meetings, and participation and/or lead the writing of a number of manuscripts and grants.

Public health relevance
PROJECT NARRATIVE The identification of super-enhancers in ovarian cancer that contribute to growth and therapeutic response will be instrumental in diagnostic, prognostic, and therapeutic decision making. Not only will this work identify ovarian cancer-specific super-enhancers, but it will also determine how they are modified in response to standard-of-care chemotherapies, as well as identify new drugs to target them directly. By better understanding the location and functional role of these master transcriptional hubs in ovarian cancer, we can more specifically treat each ovarian cancer patient to achieve the best possible outcome.